ENDOCRINE EVALUATION OF PATIENTS WITH DISEASES OF THE PITUITARY

This clinical protocol has been utilized occasionally over the years for the evaluation of endocrine function in subjects with known pituitary disease. Several metabolic tests are performed during a brief stay at the GCRC to assess the patient's residual pituitary function before and after pituitary surgery.